Investigating the Regulatory Roles of Histone Chaperones in Cellular Plasticity

PROJECT SUMMARY
Histone chaperones are functionally and structurally diverse proteins. They play a central role in chromatin
organization and maintenance by binding to histones and facilitating nucleosome assembly during DNA
replication, transcription, recombination and repair processes. Moreover, some histone chaperones evolved
additional functions independent of histone binding. Histone chaperones are thus essential for cellular
proliferation and organismal development. Intriguingly, circumventing this lethality in a number of cell fate
change paradigms revealed roles of histone chaperones in cellular plasticity. For example, we and others have
shown that the chromatin assembly factor 1 (CAF-1), a histone chaperone complex involved in replication
dependent nucleosome assembly and heterochromatin regulation, prevents cellular reprogramming. More
recently, we demonstrated that CAF-1 maintains lineage integrity of stem and progenitor cells by repressing
the transcription of differentiation genes. In this context, CAF-1 controls chromatin accessibility at
enhancer/promoter elements of lineage specific loci and prevents aberrant binding of transcription factors. In
addition to these CAF-1 sensitive sites, we also identified heterochromatic loci whose accessibility is perturbed
upon CAF-1 loss, albeit with unknown effects on cell fate. The influence of CAF-1 on local euchromatic and
heterochromatic loci is intriguing given that CAF-1 acts in a sequence independent manner to assemble
nucleosomes during DNA replication. Whether such profound effects of CAF-1 on cell fate are linked to its
nucleosome assembly function or additional non-canonical functions remain unexplored. Moreover, given the
growing repertoire of histone chaperones and associated histone variants, it remains unclear whether CAF-1
cooperates with other histone chaperones to maintain lineage integrity. Therefore, the functional and structural
determinants of the histone chaperone network as a whole in the context of cell fate remain important open
questions. To investigate the molecular mechanisms underlying the lineage specifying functions of histone
chaperones, we will use well established cell fate change paradigms in combination with gene editing/RNAi,
multi-omics, biochemical and functional approaches. Specifically, we propose the following two research
directions: (1) Investigate the regulatory mechanisms and function of histone chaperone sensitive chromatin
sites and, (2) interrogate the structure-function relationships of histone chaperones and how their domains are
intimately linked to control cell fate. In the short-term, we plan to dissect the epigenome and structural
determinants of CAF-1. In the long-term we plan to extend our analysis to other histone chaperones pathways
and how they cooperate with CAF-1 to control cell fate. If successful, our studies will contribute to design
strategies for manipulating histone chaperone pathways to control cell fate in health and disease.

Public health relevance
PROJECT NARRATIVE Histone Chaperones are emerging as regulators of cell fate decisions given their pivotal role in genome organization during DNA templated processes such as DNA replication and transcription. The goal of this research proposal is to understand the molecular mechanisms underlying the lineage specifying functions of histones chaperones. If successful, our work will be a stepping stone to developing new therapies and technologies where histone chaperone pathways can be manipulated to control cell fate.